Ingestible Pill for spatially targeted sampling of gut microbiome

Project Summary
This R21/R33 proposal is submitted in response to PAR-20-133. The proposal focuses on the development of
an ingestible device termed “micro-pill”. The micro-pill will be designed to autonomously sample intestinal
content from predetermined anatomical sites in the gastrointestinal (GI) tract, a process which currently
requires invasive methods. The development of the micro-pill benefits from the applicants' experimentation
with an earlier version of the pill that utilizes an osmotic pump for sampling. To ensure accurate sampling of GI
luminal content from specific anatomical sites, the micro-pill will be fitted with a miniaturized motor controlled
by pH and pO2 sensors. The concept takes advantage of the proximal-to-distal rising pH and falling oxygen
gradient, such that the micro-pill will sample autonomously based on pre-programmed pH and O2 thresholds.
This innovative control mechanism is optimal for this application because it dispenses with the need for
tomography or built-in camera that may be needed to track the pill's location for spatially selective sampling.
The new micro-pill will run on power from a coin cell battery and will also support wireless magnetic activation
in individuals where pH/pO2 levels may be altered due to atypical GI tract conditions. The architecture of the
micro-pill is optimized to enable sampling of viscous intestinal content and reduce leakage and contamination,
while maximizing the volume of sample collected and maintaining low specific weight for improved buoyancy
and motility through the GI tract.
During the R21 phase micro-pill prototypes will be built and tested in vitro in conditions simulating the viscosity
of the GI lumen and ex vivo in pig intestines. Optimized designs will be tested in live pigs. The R21 phase is
organized in 3 specific aims: (1), To design, fabricate and validate in vitro a motorized micro-pill; (2) To design,
integrate and test pH/pO2 sensors in vitro and ex vivo using electronics integrated in the micro-pill; (3) To test
the ingestible micro-pill in live pigs in vivo. The aims of the R33 phase are to assess the efficacy of the micro-
pill (4) and conducting a 2-phase randomized controlled cross-over diet trial in humans (5). In Specific aim 4
the feasibility of sampling human adults' luminal content from pre-determined GI tract regions will be tested in a
clinical trial. The trial will not only assess the micro-pill's function, but also compare the effects of a plant-based
and a meat-based diet on the GI tract microbiota collected from different anatomical GI sites.
This proposal was conceived by three Tufts University researchers with complementary expertise. PI Dr.
Sameer Sonkusale from the School of Engineering heads an interdisciplinary Nano Lab and specializes in
micro- and nano-fabrication, and biomedical devices. Dr. Giovanni Widmer from the School of Veterinary
Medicine has extensive experience with animal models, microbiota analysis and bioinformatics. Dr. Alice H
Lichtenstein at the Jean Mayer USDA Human Nutrition Research Center for Aging brings to the project years
of experience with diet-related human intervention trials.

Public health relevance
Project Narrative To characterize the intestinal microbiota populating different sites of the gastrointestinal tract, we propose to develop an ingestible device termed “micro-pill”. The 3D-printed micro-pill will be fitted with pH and oxygen sensors such that it can sample autonomously from pre-determined intestinal sites after ingestion. Given the importance of the intestinal microflora to health and disease, the ability to non-invasively sample intestinal microbial populations throughout the GI tract will facilitate the development of precision nutritional prescriptions aimed at optimizing long-term health outcomes.